CORE--PATHOLOGY

The purpose of the Pathology Shared Resource (Pathology Shared Resource) is to provide modern comprehensive pathology services to San Antonio Cancer Institute (SACI) investigators. These services include: * Routine histology and histochemistry (e.g. H&E stained slides). * Non routine histology and histochemistry (e.g. microdissection and special stains). * Immunohistochemistry (with fluorescent and enzyme detection systems). * Tissue/tumor banking (of fresh-frozen and fixed-archival specimens). * Collaboration/consultation with experienced technicians and pathologists. Computerized database of results.